Evaluating Early and Late Functional, Immune and Angiogenic Responses to Injected Cardiac Fibroblast Derived Matrix in a Myocardial Infarction Model

Abstract
Cellular Logistics’ (CL) innovation in biomaterials offers a solution to limit and reverse damage caused by
myocardial infarction (MI). Over 805,000 Americans suffer a myocardial infarction (MI) each year. Survival
following MI has improved largely due to improved acute systems of care designed to accelerate coronary
artery reperfusion. However, large and/or repeated MIs are common and remain a major cause of heart failure
(HF) hospitalizations and death. Standard therapy to prevent post-MI HF involve medications that block
maladaptive neurohormonal pathways, but these drugs are partially effective and are not universally tolerated.
For those who progress to end-stage HF, cardiac transplantation may be lifesaving; however, the supply of
donor organs is far outpaced by patient need and complications associated with transplantation are
substantial. This growing unmet need has fueled the concept of scaffold therapies to repair the failing heart.
The product of CL’s proposed SBIR will be the cardiac fibroblast derived extracellular matrix (CF-ECM), an
injectable acellular biomaterial as standalone MI therapy. Derived from the culture of human cardiac fibroblasts
(CF), CF-ECM has a unique protein composition that is composed primarily of insoluble fibronectin, an
extracellular matrix protein that is known to have an important role in cardiac healing. CF-ECM is thought to
work by influencing the healing response, specifically, by modulating the immune system and inducing new
blood vessel growth. CF-ECM also attaches to the myocardium when injected into the heart, boosting its
therapeutic benefits. The long-term goal of this SBIR is to develop CF-ECM as a standalone therapeutic to
accelerate post-MI healing, thereby limiting infarct expansion, post-MI deleterious remodeling, and the
progression to HF. We hypothesize that the early effects of CF-ECM are to modulate the immune system to an
anti-inflammatory state and increases angiogenesis in the damaged myocardium. Furthermore, we
hypothesize that CF-ECM is safe and improve cardiac function and reduce maladaptive remodeling, thereby
reducing the progression to HF. CL has determined that CF-ECM has significant commercial opportunity: With
~805,000 MI patients in the US each year, the estimated market size for CF-ECM is ~$2B/year with an
estimated CAGR of 2.7% between 2021 and 2026. CL’s innovative biomaterial has the potential to limit post-MI
damage—an important step toward confronting the burgeoning HF epidemic.

Public health relevance
Narrative Over 805,000 Americans suffer heart attacks annually; the damaged caused by a heart attack is the leading cause of heart failure, which is the number one reason for hospitalization of people over the age of 65 and is deadly. A therapy that can be administered immediately following a heart attack that limits the damaged could significantly reduce the progression to heart failure and is sorely needed. Cellular Logistics is developing a therapeutic material that, when injected into the heart after a heart attack, can induce the body to heal itself and limit the damage resulting from the heart attack, thus improving the heart’s health and reducing the likelihood of a patient developing heart failure.